INTRAVENOUS CHALLENGE WITH L TRYPTOPHAN ACROSS THE MENSTRUAL CYCLE

The specific aims to this study are to: 1) generate a normal neuroendocrine response curve to LTP across the menstrual cycle; 2) establish patterns of cyclic variations in serotonin concentration across the menstrual cycle in normal women with PDMM; and 3) assess in a similar fashion age and body mass matched, healthy subjects with prospectively documented PDMM and to compare the response curve with that of normal controls.